Acquisition of a Zebrafish Housing and Breeding System for the University of Mississippi Aquatics Facility

Project Summary: Zebrafish, Danio rerio, is an incredibly useful model organism in biomedical
research. The vast number of genetic mutants, ease of phenotypic screening, and transparency
during early development have enabled molecular understanding of many human diseases.
Mirroring the national trend of increased use of this model organism, the number of researchers
at the University of Mississippi (UM) using and proposing to use zebrafish is expanding. The
goal of this proposal is to support the acquisition of the latest technologically advanced zebrafish
culture systems to expand the capabilities of the zebrafish researchers. Optimum culture
conditions and monitoring and alerting functions are essential to maintain ideal health and
reproduction in our aquatic facility. The UM Aquatic Facility includes eight rooms, three set aside
for routine animal culture. While one room has utilized a similar Aquaneering system since 2018,
and two single rack systems were purchased with new grant funds (November 2023, August
2024), there is an acute need to modernize the remaining culture room to accommodate the
needs of the current researchers and facilitate needed faculty recruitment. Specifically, this
proposal will implement in Faser 300E, three single-sided and one double-sided 6-shelf racks
and include all the monitoring, dosing, and heating necessary to ensure healthy zebrafish
culture. Incorporating these systems will allow us to buffer infrastructural inconsistencies (water
and heating) in our 50-year-old building. Furthermore, including the 100 L AquaSpawner
chamber, hooked into the system water flow, will provide us with new capabilities to generate
thousands of embryos replicating the zebrafish’s preferred spawning conditions while minimizing
animal handling. Zebrafish researchers at UM have been and are supported by two NIGMS
COBRE centers, NIEHS, NICHD, NIDA, and the American Heart Association, with

Public health relevance
Project Narrative To ensure optimal health and reproduction in zebrafish culture facilities, housing systems that circulate water and control and monitor pH, conductivity, temperature, water level, and dissolved oxygen are state-of-the-art. By incorporating new aquatic housing and breeding systems in the shared-use University of Mississippi Aquatic Facility, we will meet the zebrafish culture needs to accommodate increasing demands of UM researchers and overcome deficiencies in facility infrastructure.